Precision Medicine Digital Twins for Alzheimer’s Target and Drug Discovery and Longevity

PROJECT SUMMARY
Alzheimer’s disease (AD) is a devastating neurodegenerative disease and it is lack of effective disease-modifying
treatments. Medical digital twins are computational disease models for target identification and drug discovery.
However, how to organize and prioritize drug targets and candidate AD treatments in digital twins at drugome-
wide and genome-wide scales are challenging. Our team developed AlzGPS, a genome-wide positioning
systems platform to catalyze multi-omics for AD drug discovery. We also created The Alzheimer’s Cell Atlas
(TACA), a single-cell transcriptomics and network pathobiology map for target identification and drug repurposing
at brain cellulome-wide scales. We demonstrated that systematic identification and characterization of underlying
pathogenesis and disease progression at cellulome- and genome-wide scales, will serve as a foundation for
identifying and validating disease-modifying targets and treatments in AD or even longevity. We hypothesize that
the digital twins tools for coordinated acquisition and seamless curation of multimodal data will be transferrable
to any aging therapeutic development domains and will be applicable beyond digital twins, to expand artificial
intelligence (AI) and machine learning (AI\ML) workflows in AD target and drug discovery. We thus posit that a
drugome-wide and genome-wide, precision medicine digital twins platform that identifies likely causal AD genes
and networks from human genome sequencing and multi-omics findings, enables a more complete mechanistic
understanding of AD pathobiology and the rapid development of disease-modifying targets and treatments with
great success. Our goal is to ethically acquire and responsibly disseminate comprehensive patient-specific
multimodal data sets, which will form the basis for scientific, technological, and translational studies to design
and evaluate digital twins, and explore their integration to AD target and drug discovery. Aim 1 will develop and
test an interpretable mechanistic deep learning framework to identify disease-modifying targets and networks
for AD and longevity. We will develop a human protein-protein interactome network topology-based deep
learning framework (R21 phase) and identify putative drug targets for AD and longevity through integrating
multimodal data (genetics, genomics, transcriptomics, proteomics, and clinical) from AD sequencing project
(ADSP), the AD knowledge portal, Longevity Consortium, and the Accelerating Medicines Partnership-AD (R33
phase). Aim 2 will develop and apply AI\ML technologies for collaborative end-to-end analyses of single-cell
multi-ome data. We will develop and implement a graph embedded gaussian mixture variational autoencoder
network algorithm (R21 phase) and identify AD cell type-specific genes/targets, regulatory networks, and ligand-
receptor interactions (R33 phase). Aim 3 will implement and test precision medicine Digital Twins for drug
repurposing in AD and AD-related dementia (R33 phase). All Digital Twins codes, toolbox packages, and data
developed will be shared through the ADSP and the AD knowledge portal based on the FAIR principles. This
project is highly feasible and potentially transformative for both Alzheimer’s data science and precision medicine.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the leading cause of dementia and the sixth leading cause of death in the United States, while the current disease incidence indicates approximately 13.8 million Americans will be affected by 2050 without effective disease-modifying treatments. This proposal will develop an intelligent digital twins platform (including artificial intelligence and machine learning tools), capable of identifying and validating human genome sequencing findings for Alzheimer’s target and drug discovery. The innovative digital twins toolboxes and drug targets developed in this project will prove to be novel and effective ways to rapidly identify effective treatment approaches for AD and AD-related dementia, an essential goal of Alzheimer’s precision medicine.